A Personalized mHealth Approach to Smoking Cessation for Veterans Living with HIV

Although smoking is a significant cause of damage to health and quality of life specifically for Veterans
with human immunodeficiency virus (HIV), smoking cessation interventions for this population are lacking. Dr.
Wilson’s proposed CDA-2 projects will develop and test a mobile health (mHealth) intervention called Mobile
Contingency Management plus Evidence-Based Smoking Cessation for HIV-positive Veterans (MESH). The
MESH intervention uses mHealth and telehealth technology to a) individually personalize smoking cessation
counseling and pharmacotherapy, b) deliver reinforcement for smoking abstinence, and c) provide relapse-
prevention messaging support. It is a personalized, tailored, multi-component intervention for smoking
cessation specifically designed for Veteran smokers living with HIV. Specific aims are as follows:
Aim 1: To qualitatively explore smoking cessation treatment preferences among Veteran smokers living
with HIV, and to quantitively evaluate perspectives on relapse-prevention messages among Veterans and
smokers living with HIV. We will complete N = 20 semi-structured interviews with VHA HIV patients (initial
treatment tailoring phase) and subsequently complete N = 400 quantitative rapid online surveys (secondary
user satisfaction data). Results will be used to refine design/content of the proposed intervention.
Aim 2: To use a successive cohort design to develop and obtain patient feedback on an mHealth
smoking cessation intervention that uses computerized algorithms to personalize treatment. We will collect
qualitative data on 3 cohorts of n = 5 Veteran smokers with HIV. Results from each cohort will be iteratively
used to modify the MESH treatment design/content/user experience.
Aim 3: To determine the feasibility and acceptability of MESH. After finalizing design of the mHealth
app, we will conduct a trial in which N = 30 Veteran smokers with HIV will be randomized to either MESH or to
a comparison condition (VA Quitline and SmokefreeVET). Outcomes include feasibility of the overall approach
and acceptability of the intervention. Tests of efficacy are not appropriate given power considerations and the
overall focus on treatment development. Results will be used in an IIR application in Year 3 of the timeline.
While the IIR design may change, I plan to propose a Hybrid Type 1 implementation-effectiveness design to
test effectiveness of the MESH intervention while collecting preliminary clinic-level implementation data.
Aim 4: To quantitatively examine trends and determine health disparities in use of smoking cessation
aids among patients living with HIV and receiving VHA clinical care. I will leverage two large national VA
cohorts to compare smoking cessation pharmacotherapy prescriptions by demographic group and medical
comorbidity. I expect to detect disparities in pharmacotherapy prescription rates by medical comorbidity (e.g.,
pain, Hepatitis C coinfection) and demographic group (e.g., ethnicity). Results will enable future examination of
whether MESH may help overcome existing disparities.
This CDA-2 application is highly significant given that: 1) Smoking is prevalent among and particularly
harmful for HIV-positive Veterans; 2) There is a dearth of research on smoking cessation for Veterans with
HIV; 3) Current approaches to smoking cessation in this population are not efficacious; 4) As the largest U.S.
provider of HIV health services, VHA is an ideal setting; and 5) The proposed intervention follows the VA
Blueprint for Excellence, which prioritizes mHealth and treatment personalization to increase reach/efficacy.
This CDA-2 application is innovative and unique in the following ways: 1) It is the first multi-component
mHealth intervention for HIV-positive Veteran smokers that individually personalizes treatment; 2) Previous
interventions have not attempted to maintain abstinence effects of behavioral reinforcement by offering
relapse-prevention messaging; and 3) There is currently little knowledge of health disparities in VHA
prescriptions for smoking cessation pharmacotherapy among Veterans with HIV.

Public health relevance
Veterans living with HIV smoke at higher rates than Veterans without HIV, and quit rates among smokers with HIV are low. Despite smoking-related mortality and morbidity among HIV-positive Veterans, smoking cessation research in this population is lacking. Among Veteran smokers with HIV, behavioral/pharmacological smoking cessation treatments are underutilized and furthermore may have low efficacy. The proposed CDA-2 projects use technology to optimize the reach and efficacy of smoking cessation treatment. The intervention (MESH: Mobile Contingency Management plus Evidence-Based Smoking Cessation for HIV-Positive Veterans) uses mobile health and telehealth technology to deliver a) individually personalized smoking cessation counseling and pharmacotherapy, b) behavioral reinforcement for abstinence, and c) relapse-prevention messaging. Proposed projects focus on iterative intervention design and feasibility testing in preparation for a larger trial.